Cellular and Molecular Analysis Core

The Cellular and Molecular Analysis Core (CMAC) is composed of 3 independent, but complementary
and collaborative, cores that educate Center investigators, offer consultations about core services, and
provide access to state-of-the-art methods and technologies. CMAC cores and services include 1) The
Musculoskeletal Cell Core (MCC) directed by Drs. Divieti Pajevic and Gerstenfeld, which provides highly
annotated human musculoskeletal tissues, human and model organism primary musculoskeletal cells, and
control or genetically modified cell lines. The core also offers hands-on training on isolation and
characterization of musculoskeletal cells and will optimize protocols for the isolation of circulating
osteoprogenitor cells. 2) The RNA Sequencing and Spatial Transcriptomics Core (RSTC) directed by Dr.
Matthew Warman, which advises about bulk and single cell RNA sequencing study design, sample size
requirements, RNA and single cell extraction protocols, and data analysis pipelines and programs. The
core also performs and provides hands-on training in spatial transcriptomics using Light-Seq, a pioneering,
open-source, and inexpensive spatial transcriptomics technology. 3) The Directed Differentiation Core
(DDC) directed by Dr. April Craft, is a new core requested by Center members and the Innovation
Committee. The DDC provides hands-on training and the use of lab space, cells, equipment, and lot-tested
reagents to generate musculoskeletal lineage cells from pluripotent, or multipotent, human and mouse stem
cells. Services provided by the CMAC are rigorously quality controlled. The Core educates Center
members about current capabilities and emerging technologies by offering workshops focusing on a specific
technology, seminars that described how a Core service helped lead to important scientific discoveries,
one-on-one consultations, and hands-on training sessions during which Center members are mentored and
taught how to perform assays, cell manipulations, and RNA sequencing on their own. The CMAC has
evolved so it will continue to have a major impact on Center members’ musculoskeletal research, and be
especially helpful to early-stage investigators and investigators who are new to musculoskeletal science.